Development of circRNA manufacturing platform in yeast

SUMMARY:
Circular RNAs (circRNAs) are a novel class of RNAs that hold immense potential as therapeutics due to
their unique cellular functions. However, the challenges associated with their synthesis and purification have
impeded their research and development. Chimerna proposes to develop a platform technology using yeast
to manufacture high-quality circRNAs for use in research, therapeutics, and diagnostics. The proposed
technology builds upon Chimerna's Tornado technology for expressing RNAs as a circle in cells. When
used in E. coli, the Tornado technology results in the production of RNA at high levels not previously seen
with conventional linear RNAs. The stability of circular RNA allows it to accumulate to high levels in E. coli,
and also confers high stability in vitro and when transfected into mammalian cells, thus mitigating the
persistent degradation problem of conventional linear RNAs. The project also utilizes a proprietary affinity
tag that is encoded into the circRNA making downstream purification easier. This technology resolves key
problems associated with current circular RNA synthesis methods that use in vitro transcription for
production. However, production of circRNA in E. coli results in high levels of LPS, which is difficult to
remove and not acceptable for therapeutic indications. The current proposal aims to engineer a yeast strain
capable of producing circRNAs at high yields. Unlike bacteria, yeast do not contain LPS, which is difficult to
remove in downstream purification applications. Moreover, yeast has been extensively used for
manufacturing many bioactive compounds such as proteins and lipids. This makes yeast an ideal organism
in which to develop a circRNA manufacturing platform. The specific aims of the project are: (1) - To
engineer a yeast strain that can be induced to express circular RNA at high yields: This aim involves
engineering multiple yeast strains to produce circRNAs and testing their yield under various inducible
promoters. The yeast strain will be further optimized by introducing RNA processing enzymes required for
maximum circularization efficiency; (2) To benchmark circRNA manufacturing to existing manufacturing
technologies: The second aim of the project involves comparing the yield and cost per gram of RNA
produced in yeast versus traditional IVT. The researchers will also examine protein expression and RNA
half-life from a circular mRNA versus a linear mRNA for total protein output in mammalian cells. Finally, they
will measure inflammatory responses to transfected circRNAs versus linear mRNAs. Taken together, the
development of a yeast manufacturing platform for synthesizing circRNAs holds immense promise for the
production of this highly important type of RNA. The proposed technology will greatly reduce the cost of
producing circRNAs while also simplifying the purification and downstream processing. This new
manufacturing platform will accelerate the entry of circRNAs for medical use, thereby advancing the field of
RNA therapeutics.

Public health relevance
PROJECT NARRATIVE RNA vaccines and therapeutics have gained a lot of attention following the success of the mRNA-based COVID-19 vaccines and many new companies are entering the field. The sudden need for vast quantities of RNAs to be manufactured is hampered by significant supply chain issues and a lack of expertise. This proposal will result in a new method for manufacturing circular mRNAs using well-established yeast expression systems that aims to reduce the delays and costs associated with manufacturing and simplify purification for downstream applications.